Investigating and targeting metabolic vulnerabilities of MYC-driven small cell lung cancer

PROJECT ABSTRACT
Small cell lung cancer (SCLC) is a fatal neuroendocrine lung tumor that is challenging to treat due to
early metastasis, rapid growth, and a lack of easily targetable driver alterations. For the last ~40 years, SCLC
has been treated primarily as a single disease in the clinic with combination, platinum-based chemotherapy that
offers a median survival of only ~10-12 months. It is imperative to better understand SCLC biology to enable
development of novel treatment strategies that effectively prolong patient survival. SCLC tumors amplify or
overexpress one oncogenic MYC family member: MYC, MYCL, or MYCN. MYC-high SCLCs are metabolically
distinct from MYC-low, and have specific and targetable metabolic vulnerabilities. The most effective therapeutic
strategy for treatment of MYC-high SCLCs in preclinical trials is deprivation of circulating arginine by pegylated
arginine deiminase (ADI-PEG20). MYC-high SCLCs are particularly sensitive to ADI-PEG20, because they lack
the enzyme argininosuccinate synthetase 1 (ASS1) that catalyzes de novo synthesis of arginine by the urea
cycle. Still, SCLC tumors eventually develop resistance to ADI-PEG20 (ADIR) that corresponds with re-
expression of ASS1. Upon ADIR, tumors acquire secondary metabolic dependencies that may be targeted to
prolong ADI-PEG20 response and patient survival. Preliminary data show that ADIR SCLC depends on serine
and one-carbon (1C) metabolism, which can be targeted with anti-folates. Preliminary data also delineate
candidate transcriptional regulators that may govern ADIR in SCLC. Activating transcription factor 4 (ATF4), a
stress-responsive transcription factor, is one predicted upstream regulator of gene programs enriched in ADIR
vs naïve SCLCs—determined by bulk and single-cell RNA sequencing. ATF4 is induced upon acute arginine
deprivation in SCLC and continues to be expressed with its target genes during ADIR. Here, the applicant will
employ a single-cell RNA-seq-derived model of SCLC response to ADI-PEG20, metabolite profiling, in vivo
isotope tracing, and CRISPR-based gene editing to interrogate whether ATF4 governs ADIR. The hypothesis for
this research is that ATF4 drives ADIR by enhancing serine and 1C metabolism in an ASS1-dependent manner.
Experiments will be performed in two specific aims to test whether ATF4 governs: 1) the sensitivity of MYC-high
SCLCs to ADI-PEG20, and/or 2) the sensitivity of ADIR SCLCs to 1C metabolism inhibitors. Knowledge gleaned
from this research will inform combination treatment strategies that improve the efficacy of ADI-PEG20 and
extend survival of patients with SCLC and other ASS1-low tumors. The proposed research will provide unique
opportunities for the applicant to gain expertise in cancer biology, cancer metabolism, and computational
analysis of -omics data—three major goals of the applicant’s training plan. The proposed research will occur
over three years of training at Huntsman Cancer Institute and the University of Utah, a collaborative and
resource-rich training environment, in the lab of Dr. Trudy Oliver.

Public health relevance
PROJECT NARRATIVE Small cell lung cancer (SCLC) is the deadliest and most difficult-to-treat subtype of lung cancer with a standard-of-care that has remained largely unchanged for decades. Arginine deprivation by pegylated arginine deiminase (ADI-PEG20) is the most effective targeted therapy in preclinical studies of MYC-driven SCLC, but tumors eventually become resistant to ADI-PEG20. In accordance with NIH’s mission to advance human health, this study will interrogate mechanisms of ADI-PEG20 resistance to identify therapeutic strategies that prolong the efficacy of ADI-PEG20 and improve survival of patients with SCLC.